Donor DNMT3a-mediated regulation of Graft-vs-Host-Disease and the Graft-vs-Tumor effect in allogeneic hematopoietic cell transplantation

PROJECT SUMMARY/ABSTRACT
Background: Allogeneic hematopoietic cell transplant (allo-HCT) remains the only curative therapy for many
aggressive malignancies and is increasingly used for non-malignant disorders. Success is limited by 1) relapse
due to insufficient graft-vs-tumor (GVT) activity and 2) graft-vs-host disease (GVHD). Current GVHD therapies
predispose to infection and relapse. Understanding the mechanisms that optimize GVT activity and mitigate
GVHD remains a critical unmet need. Donor T-cells are essential to the allogeneic immune response. De novo
DNA methylation by DNMT3a allows activated T-cells to acquire patterns of gene expression that define
alloreactivity. Human donor DNMT3a mutations result in decreased relapse, increased GVHD, and improved
survival in HCT recipients. Based on a large body of preliminary data, both GVHD and GVT activity significantly
depend upon DNA methylation, the role of which is largely unknown in the HCT context. I hypothesize that
targeting epigenetically controlled pathways can skew allogeneic immunity away from host and towards tumor.
Design: Mice with cell-lineage specific DNMT3a deletion will be used as donors in well-established, clinically
relevant, murine models of HCT. Following HCT, donor cells will be isolated from recipient mice and undergo
whole genome bisulfite sequencing (WGBS) and RNA sequencing (RNAseq) in parallel. This novel approach,
proven to be feasible and successful in my preliminary work, produces a comprehensive epigenetic and
transcriptomic profile of the cells directly involved in the pathogenesis of GVHD and the GVT effect. Importantly,
this method readily identifies the pathways that are dysregulated in the absence of DNMT3a.
Aim 1: Target epigenetically regulated pathways to mitigate GVHD. Dnmt3a KO donor T-cells accelerate GVHD.
WGBS and RNAseq post-HCT identified multiple pathways, normally silenced by DNMT3a, that may contribute
to this phenomenon. We will explore these putative novel targets, starting with CCR9, a chemokine receptor that
guides T-cells to the intestine, a major GVHD target organ.
Aim 2: Determine the contribution of myeloid cell DNMT3a deletion to enhanced GVHD and GVT activity.
Myeloid-derived cells hold significant immunoregulatory potential. The impact of myeloid DNMT3a deletion is
unknown. We will use donors with myeloid Dnmt3a deletion to test this.
Aim 3: Identify genes that distinguish beneficial GVT activity from harmful GVHD via epigenetic and
transcriptomic comparative analyses. In GVT models, where allo-HCT is performed in the presence of leukemia,
KO T-cells provide superior disease control. We will apply WGBS and RNAseq to interrogate how the presence
of tumor alters the epigenome and identify the changes that allow KO T-cells to better eradicate leukemia.
My long-term goal is to become an independent laboratory-based clinician-scientist, focusing on complications
of HCT and novel therapeutic approaches. My aims and training plan have been specifically and thoughtfully
crafted to provide me with the research skills and experience needed to reach this goal.

Public health relevance
PROJECT NARRATIVE Allogeneic hematopoietic stem cell transplant (HCT) remains the only curative therapy for many aggressive malignancies and is increasingly used for non-malignant disorders, but successful outcomes are limited by graft- vs-host-disease (GVHD) and inadequate graft-vs-tumor (GVT) activity. De novo DNA methylation catalyzed by DNMT3a is a major epigenetic mechanism that controls the post-HCT immune response. This project will define the DNMT3a-dependent pathways that can be targeted in the regulation and separation of harmful GVHD from beneficial GVT activity, which remains a critical unmet need toward improving patient outcomes.